Equipment and Instrument Infrastructure Improvement for the MMRRC at UC Davis

Equipment and Instrument Infrastructure Improvement for the MMRRC at UC Davis
ABSTRACT & SCOPE OF WORK
The Mutant Mouse Resource and Research Center at the University of California, Davis (MMRRC) is pleased
to submit this administrative supplement for up to 1 year of support in response to ORIP’s participation in PA-
20-272, “Administrative Supplements to Existing NIH Grants and Cooperative Agreements” specifically related
to support alterations and renovations (A&R) of facilities and/or purchase of instruments and equipment in
support of non-AIDS research. This application proposes the purchase and installation of equipment and
instrumentation to ensure and increase the quality, rigor, and capability of husbandry, production, and
phenotyping of mutant mouse lines by the MMRRC. Doing so will increase the capability and services of the
MMRRC for meeting the needs of the biomedical research community conducting NIH-funded research.
Specifically, this application requests funds to enhance and expand capacity and functionality of our existing
SPF-vivaria facilities by 1) upgrading extant individually-ventilated mouse caging system, adding specialized
environmental housing capacity, and installing a water bottle filling station to substantially increase the quality
and capacity of specific pathogen-free (SPF) housing for MMRRC mice; 2) obtaining and incorporating
specialized instrumentation and equipment to facilitate new and implement improvements to mouse
phenotyping capabilities that add substantively to research integrity, rigor, and reproducibility, 3) procuring and
operating laboratory instrumentation for in vitro reagent preparation and quality control/quality assurance
processes and for in vivo production of mutant mouse lines. Funding of this project will accomplish 5 things.
First, it will dramatically increase specialized and high-quality mouse housing capacity that enable additional
and more complex mouse-related studies than we can currently perform simultaneously, thus accelerating and
extending our abilities to respond to a greater variety of researcher needs and in a more-timely manner than
currently. Second, it will expand existing and enable new and innovative phenotyping modalities to respond to
users’ needs for more extensive and comprehensive testing and analysis of their mutant mouse lines,
especially in musculoskeletal, physiological, and behavioral phenotyping of male and female cohorts, aging
mice, and under challenge (e.g., diet, infectious disease, etc) conditions. Third, it will improve rigor,
reproducibility, and transparency in production and phenotyping activities. Fourth, it will enable more cost-
efficient operations and services for user of the MMRRC, such as monitoring body weight kinetics, performing
necropsy and harvesting and archiving tissues (organs, cells, blood, intestinal contents, DNA, urine, etc) that
will be made available to researchers upon request online at www.mmrrc.org. Fifth, it will further support efforts
by the MMRRC to be granted approved vendor status by institutions across the country, facilitating rapid
dissemination and sharing of mouse lines to requesting investigators. Together, these upgrades will
significantly enhance our ability to meet the increased expectations of MMRRC clientele for fully verified and
validated mouse models and optimized production and phenotyping services. Further, because these
upgrades are MMRRC-project specific, they are beyond the support provided by the UC Davis campus for
basic operations and maintenance. This proposal directly addresses a number of the stated objectives of this
special NIH call. The parent peer-reviewed NIH funded grant (U42OD012210) has been competitively renewed
(as of January 1, 2020) for 5 years. A budget of $424,235 direct costs ($426,218 total costs) requested for the
remaining months of the current grant year (until January 31, 2022) is less than half the annual total direct cost
budget of the parent grant. The proposed activities all fall within the scope of the parent award, which includes
archiving, phenotyping, and distributing investigator-derived and Center-produced mutant mouse lines.

Public health relevance
Equipment and Instrument Infrastructure Improvement for the MMRRC at UC Davis PROJECT NARRATIVE This proposal from the Mutant Mouse Resource and Research Center at UC Davis (MMRRC-UC Davis) seeks to address a number of the stated objectives of the call to support alterations and renovations (A&R) of facilities and/or purchase of instruments and equipment in support of non-AIDS research in response to NIH PA-20-272, Administrative Supplements to Existing NIH Grants and Cooperative Agreements. Specifically, this application requests funds to 1) purchase and install additional individually-ventilated mouse caging and related husbandry equipment to substantially increase specific pathogen-free (SPF) housing capacity and quality of care; 2) obtain and utilize specialized instrumentation and equipment to facilitate new and improved mouse phenotyping capabilities that add substantively to research integrity, rigor, and reproducibility, and 3) procure and operate laboratory instrumentation for in vitro reagent preparation and quality control/quality assurance processes prior to in vivo production and phenotyping of mutant mouse lines. Doing so will increase the capability and services of the MMRRC for meeting the needs of the biomedical research community conducting NIH-funded research.